SOCIAL COGNITION AND EMOTIONAL AGING IN PRIMATES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is an on-going grant, part of a larger program project grant (PO1), to study comparative aging from a cognitive and neurological perspective in chimpanzees, humans and rhesus monkeys. Chimpanzees and monkeys have completed 1 of the 2 computer tasks for Project 2 and personnel on Project 2 are completing daily testing for other components of the P01. New tasks are being developed and data are being analyzed as individuals finish various components.